Host-Microbe Interactions

This application requests support to continue the Host-Microbe Interactions (HMI) Predoctoral
Training Program which is an interdisciplinary training program that seeks to provide research
and curricular-based training to a pool of talented and highly motivated students who seek training
in microbial pathogenesis and beneficial host-microbe interactions. The HMI program consists of
18 Training Faculty who have an average of $736,699 direct costs per year, and annual direct
costs for research total to $13.3 million. Trainers currently have 72 trainees in their labs. Areas of
strength among our Trainers include molecular genetics of bacterial, fungal, and viral
pathogenesis, and prion biology, study of the microbiome, interaction with immune and epithelial
cells, and ecological modeling. These areas are pursued using the full range of modern genetic,
molecular, biochemical, immunologic, and computational techniques. Trainees are supported by
one of three excellent multidisciplinary graduate programs, the Microbiology and Molecular
Pathogenesis program (M2P2), and the Guarini School of Graduate and Advanced Studies. We
have both hired new faculty whose research is directly aligned with the program goals, indicating
the institution’s commitment to research in microbiology and recruited to our program Dartmouth
faculty whose research in host-microbe interactions has expanded. Most importantly, our past
Trainees have been extremely successful. Of the 33 HMI Training Program Trainees who have
left Dartmouth in the past 15 years, 32 are in PhD-level careers in science and one is a high
school science teacher and thus is still leveraging their training. HMI Trainees from the past ten
years have published 83 papers. In the past four years since the last renewal, we have made
several positive changes to the program including 1) mentor training from the Center for the
Improvement of the Mentored Experiences in Research (CIMER) with 94% of our Trainers having
already completed training, 2) increased the involvement of early career or new-to-Dartmouth
faculty in program subcommittees, 3) enhanced support for preparation of F31 applications, and
4) focus of a Trainee curriculum that is broadly useful across sub-disciplines within the area of
host-microbe interactions. To continue our positive impact on the biomedical workforce, we
request to continue supporting five trainees per year.

Public health relevance
The HMI Training Program seeks to provide research training and professional development opportunities to talented and highly motivated students that have been recruited into our Trainers’ laboratories. Our Trainees gain clinical insights through attendance of Clinical Microbiology Rounds, learn programming and bioinformatics approaches, host a speaker and lead a journal club in an area of interest among other activities and opportunities. The Director and Associate Director are supported by a Professional Development Subcommittee and strong Internal and External Advisory Committees as they provide a program that will support Trainees as they launch the successful pursuit of biomedical careers that will positively impact the health of our citizens and those around the world.